Katies for Aging Research and Equity (KARE)

Project Summary
The Katies for Aging Research and Equity (KARE) program at St. Catherine University is
uniquely situated within a women-centered, minority-serving institution in St. Paul, Minnesota.
As the only funded ADAR program in the upper midwest, the KARE program has established a
successful track record of supporting MSTEM persistence among underrepresented women and
gender diverse scholars from their first year at the University through graduation. To date, 100%
of KARE graduates are on track toward careers in research along PhD, MD, MD/PhD or
Masters degree pathways. Our innovative blend of holistic mentorship, interdisciplinary
coursework, and two aging-related research experiences position each KARE Scholar to
become a successful leader in the complementary fields of Geroscience and Gerojustice.
Herein, the renewal request for the KARE program addresses the following specific aims: (1)
optimize our supportive community for KARE Scholars, (2) increase the reach and rigor of
Geroscience education, and (3) cultivate mentored Geroscience research through intramural
and extramural research opportunities.
Specifically, KARE Scholars are recruited in their first or second year in college and
receive holistic support through community building activities, journal club opportunities, career
development programming, academic and research mentorship, and networking events within
the larger regional and national aging research community. In addition to their major program of
study, scholars take courses within a cross-disciplinary Longevity and Aging minor to
complement and contextualize their disciplinary studies with an aging lens. In alignment with the
NIA’s Health Disparities Research Framework, KARE Scholars’ coursework focuses on the
environmental, sociocultural, behavioral, and biological factors that underlie age-related health
disparities among diverse populations of older adults. Importantly, each KARE Scholar is
engaged in aging-related research through multiple intramural and extramural research
opportunities. Extramural research opportunities will be primarily cultivated within KARE partner
locations including Mayo Clinic, HealthPartners Neuroscience Center, University of Minnesota-
Twin Cities, and the Midwest Aging Consortium. Through these partnerships and mentored
research with faculty experts within St. Catherine University, KARE Scholars have the
opportunity to focus on biomedical, behavioral, or clinical projects within the field of
Geroscience. Informed by the success and lessons learned in our first five years of funding, we
are confident the renewed KARE program will train diverse scholars for successful research
careers in aging.

Public health relevance
Project Narrative The Katies for Aging Research and Equity (KARE) program advances diversity in Geroscience research by educating students within a Gerojustice framework. Our successful program is housed within a women-centered, minority-serving institution and is poised to accelerate underrepresented women and gender diverse scientists for successful aging research careers. Uniquely located within a NIA-funded T32-rich regional environment, KARE Scholars are supported throughout our innovative, multi-year program to reduce health disparities among older adults.